(7) Novel imaging devices for measurement and control of tumor microenvironments

PROJECT SUMMARY/ABSTRACT Understanding the identity, location and function of cells in the tumor microenvironment is essential to understanding how they dominate tumor phenotype and contribute to dissemination and metastasis. An example of this is the tri-partite structure TMEM (for Tumor MicroEnvironment of Metastasis) consisting of the juxtaposition of a macrophage, an endothelial cell and a tumor cell which function together to act as the doorway for metastatic dissemination. We have created novel imaging technologies consisting of 1)implantable windows with embedded microfluidics that allow serial high-resolution, single-cell microscopy of the primary and metastatic sites over days to weeks, and 2)multi-modal image alignment technologies to register fixed, stained, tissue sections to each other or to the acquired intravital imaging movies. Light activated valves embedded in the microfluidic system will be used to deliver microenvironment-altering chemical (e.g. hypoxia mimetics, chemotherapy) and biological (e.g. function blocking antibodies) agents and label unmarked tissues with fluorescent antibodies, all while imaging the tissue response in real time. Intravital imaging will be used to image the tissue and provide single-cell resolution images that cover the entire tissue over time spans ranging from seconds, to days, and even weeks. Finally, motile cells will be captured, either by chemo-attraction to microfluidic chambers, or laser capture microdissection after fixation, for further expression profiling. Application of these technologies to the study of primary and secondary lesions an unprecedented ability to probe the identity, location, quantity and function of the cells composing the heterogeneous microenvironment. Further, testing, in vivo, the targeting agents affecting the distribution, function and dynamics of the cells forming TMEM, as well as and the cells with which they interact, will enable the rapid determination of those agents with best therapeutic potential. This work will determine how 1) hypoxia, ECM density, immune cell density and chemotherapy initiate and define tumor heterogeneity in the primary and secondary sites; 2) chemotherapy and known blockers of TMEM assembly and function affect the dynamics of intravasation and dissemination in the primary and secondary sites; and 3) the relationship between cellular behavior and phenotype with cellular identity and location. The techniques utilized in this project are generally applicable and will allow molecular identification, localization and quantification of tumor heterogeneity in many cancers and disease models.

Public health relevance
PROJECT NARRATIVE We have created novel imaging technologies designed to determine and record the identity, quantity, and location of each of the different cell types that contribute to tumor heterogeneity in both the breast and its major site of metastasis, the lung. These technologies consist of 1) implantable windows with embedded microfluidics that deliver chemical and biological agents, collect migratory cells, and label unmarked tissues with fluorescent antibodies, all while high-resolution, single-cell microscopy captures the tumor's real-time response in the living animal, 2) multi-modal image alignment technologies to register fixed, stained, tissue sections to each other or to the acquired intravital imaging movies. We will use these technologies to study which cells in the primary and metastatic lesions contribute to the process of breast cancer metastasis, test agents known to block signals that to contribute to the process of metastasis, and expression profile the migrating cells to understand their differences from the bulk, immotile tumor.